Action For Health In Diabetes Continuation (Look AHEAD)

DESCRIPTION (provided by applicant):Action For Health In Diabetes Continuation (Look AHEAD), responds to RFA-DK-12-502: Limited Competition for the Continuation of Look AHEAD (Action for Health in Diabetes) Consortium (U01). The aging of the population and the epidemic of obesity have led to a rapid increase in the number of older, obese individuals with diabetes. Little is known about the long-term health effects of lifestyle intervention designed to lower weight and increase physical activity in this population. This application, which responds to RFA-DK-12-502, is submitted by one of the 16 clinical centers in the Action for Health in Diabetes (Look AHEAD) Consortium. All 16 clinical sites and the Coordinating Center have submitted parallel applications. This application proposes to continue the Look AHEAD clinical trial as an observational cohort study and to follow participants with new assessments of the health problems of greatest concern in older, obese individuals with type 2 diabetes. We will test whether random assignment to 9-11 years of intensive lifestyle intervention, compared to a control condition of diabetes support and education, results in improvements in 1) physical function, impairment and disability, 2) cognitive function and impairment, 3) diabetes control and microvascular complications, 4) late life depression, and 5) fractures and cancers. Secondary aims are to examine whether subgroup differences observed during the trial (which raised concern about possible unfavorable effects of intensive lifestyle intervention in those with a prio history of cardiovascular disease) endure and whether the excellent weight losses achieved in the intensive lifestyle intervention arm are maintained despite the absence of continued intervention activities. The Continuation will also support ongoing ancillary studies, maintain infrastructure for new ancillary studies, and sustain thorough analyses and publication of the data collected by Look AHEAD. We will continue to follow the Look AHEAD cohort (approximately 4,000 participants) across the 16 clinical sites. Participants entered the trial 9-1 years ago when they were obese or overweight and aged 45-76, and were randomly assigned with equal probability to either an intensive lifestyle intervention that has induced sustained weight loss and increased physical activity or control condition (diabetes support and education). Both arms have had excellent retention. Interventions were discontinued in Sept, 2012, but follow-up of the cohort continues. This application will fund one additional clinic visit and ongoing telephone-based outcome assessment. This application builds on the remarkable success of the Look AHEAD in inducing and sustaining weight loss and retaining participants. The planned continuation addresses important public health priorities for a rapidly growing and under-studied segment of the US population in a cost-effective manner, leveraging the extensive resources available from Look AHEAD.

Public health relevance
PUBLIC HEALTH RELEVANCE: "Action For Health In Diabetes Continuation (Look AHEAD)," responds to RFA-DK-12-502: Limited Competition for the Continuation of Look AHEAD (Action for Health in Diabetes) Consortium (U01). Project Narrative The number of older, obese individuals with type 2 diabetes is rapidly increasing and little is known about the impact of lifestyle interventions during midlife on the long-term health of this population. This application seeks to continue to follow the Action for Health in Diabetes (Look AHEAD) cohort as an observational study, and to compare individuals who were randomly assigned to intensive lifestyle intervention with those assigned to the control condition on new measures of the health problems of greatest concern in this population, such as cognitive and physical function, microvascular complications, and late-life depression. __SpecificAimsTextDelimiter__ Action for Health in Diabetes Continuation (Look AHEAD-C) 2. SPECIFIC AIMS The aging of the population and the epidemic of obesity have led to a rapid increase in the number of older, obese individuals with diabetes. Little is known about the long-term health effects of lifestyle interventions designed to lower weight and increase physical activity in this population. This application builds on the extraordinary retention and adherence of the Look AHEAD trial to continue it as an observational cohort study, adding assessments of critical outcomes, to determine the long-term impact of 9-11 yrs of intensive lifestyle intervention (ILI) on the health problems of greatest concern in older, obese individuals with type 2 diabetes. Primary Hypotheses: Participants will have better profiles of healthy aging following 9-11 years of random assignment to ILI compared to Diabetes Support and Education (DSE) as indicated by differences on the following parameters: A) Physical function, impairment and disability. Older, obese individuals with diabetes are at increased risk for physical impairment and disability, resulting in dependency, poorer quality of life, and marked personal and societal costs. Preliminary self-report data from Look AHEAD and an ancillary study on a sub-group suggest that ILI reduced these conditions. Validated protocols, with objective measures, will be used to identify changes in physical function and the prevalence of functional impairment and disability in ILI vs DSE. B) Cognitive function and impairment. Diabetes and mid-life obesity independently increase the risk of mild cognitive impairment and dementia. A Look AHEAD ancillary study suggests that fewer older ILI participants have deficits in cognitive function compared to DSE, but this study was not designed to identify cases of cognitive impairment. Adding measures of cognitive function and determining the prevalence of mild cognitive impairment (MCI) and dementia in Look AHEAD will produce the first randomized clinical trial with sufficient power to determine whether ILI reduces the prevalence of cognitive impairment. C) Diabetes control and microvascular complications. Compared to DSE, ILI was associated with better glycemic control with less medication, less self-reported neuropathy, and better profiles of kidney disease markers. We will determine whether these benefits are maintained long-term and translate to fewer clinical events. We will strengthen the assessment of renal function by adding cystatin-C, continue surveillance for amputations, end stage renal disease, retinal laser surgery and autonomic neuropathy (by ECG), and add an objective measure of peripheral neuropathy. D) Late life depression. ILI was associated with greater improvements in depressive symptoms (assessed by Beck Depression Inventory) and less use of anti-depressants. Because obesity and diabetes both increase the risk of late-life depression, which has important associations with cardiovascular disease (CVD) and mortality, we will strengthen the assessment of depression by adding the Patient Health Questionnaire-9 (PHQ-9), which provides information to permit diagnosis of major and minor depression using DSM-IV criteria. E) Fractures and Cancers. ILI appeared to be beneficial for these outcomes, but further follow-up is needed to accrue sufficient power to confirm this. Secondary Aim 1. Look AHEAD observed concerning differences in the risk of CVD events, hypoglycemia, and use of medical care and costs between those individuals with no history of CVD at baseline (where ILI appeared beneficial) and those who had a history of CVD at baseline (where ILI appeared to have adverse effects). Continued follow-up of incident CVD events and other safety outcomes is critical to determine whether these differences between individuals grouped by CVD history (see preliminary studies) diminish or increase over time and depend on whether ILI occurs before or after the events. This is critical to determine whether it is appropriate to recommend weight loss lifestyle interventions to overweight and obese individuals with diabetes who have prior history of CVD. Secondary Aim 2. The ILI produced impressive sustained weight losses, with 50% maintaining 5% weight loss through 8 yrs. With stopping the ILI, there is an opportunity to explore the maintenance of this weight loss. Adding objective measures of physical activity and psychological and physiological outcomes (e.g. hormones related to appetite) will allow detailed exploration of the factors related to long-term weight loss maintenance. Additional Aims. The Continuation provides the opportunity to complete additional publications of Look AHEAD data. It creates a backbone for currently funded ancillary studies (described below) and infrastructure for new ancillary studies and for pooling data with other studies such as the Diabetes Prevention Program (DPP) and the Action to Control Cardiovascular Risk in Diabetes (ACCORD). Most participants have been genotyped on the Human CVD (IBC) and Metabochip and genetic analyses (some with DPP) are ongoing. 1